Administrative Core

Administrative Core Abstract
The Center for Mesoscale Mapping (CMM) will be an integral part of the multidisciplinary research mission of
the Athinoula A. Martinos Center for Biomedical Imaging, a collaborative research center of the Massachusetts
General Hospital and the Harvard-MIT Division of Health Sciences and Technology. Joining the strong
engineering and physical sciences, biological and neurosciences, and clinical investigation expertise for which
these partner institutions are known worldwide, the Martinos Center is a unique research environment that
provides vital synergy for the development of innovative imaging tools to advance brain science. The CMM and
the Martinos Center are intricately related. The administrative infrastructure of the CMM draws on the robust
infrastructure of the MGH Martinos Center for Biomedical Imaging to ensure efficient operation and provide multi-
level support for the integrated research, training and dissemination activities of the CMM. The overall
administrative framework of the CMM supports the specific aims of the CMM, including coordinating
administrative procedures to support cohesive research relationships between the grant’s Technology Research
& Development Projects, Collaborative Projects and Service Projects, as well as to streamline CMM operation;
providing administrative support for effective training in and dissemination of CMM-developed technologies; and
ensuring compliance with all funding agency and institutional policies and reporting requirements by interfacing
with Martinos Center and MGH administration, as well as with NIH and NIBIB program staff. This cycle, the CMM
will be led in a multi-PD/PI (MPI) framework, with Dr. Bruce Rosen (existing PI of the CMM) joined by Dr. Susie
Huang (TRD3 Lead) as MPIs of the renewal proposal. Dr. Rosen has both led the CMM during its initial cycle
and has extensive previous experience leading the earlier Center for Functional Neuroimaging Technologies
P41. Dr. Huang has led the CMM’s Collaborative and Service Users coordinating group from its inception and
been actively involved in multiple phases of the CMM, including active involvement in several TR&Ds as well as
leading new Training and Dissemination efforts. With her new role as TRD3 leader, and the planned translational
as well as basic science scope of proposed Collaborative and Service Projects, as well as her experience as PI
of the BRAIN initiative “Connectome 2.0” project, Dr. Huang has both experience in being actively involved in
several facets of the CMM during its initial funding cycle, and experience in managing large-scale NIH-supported
research programs, making her an ideal partner with Dr. Rosen in managing this multifaceted center.